Learning Health System training program: PROgRESS-- Patient/ pRactice Outcomes and Research in Effectiveness and Systems Science

PROJECT SUMMARY
The learning healthcare system is designed to “generate and apply the best evidence for the collaborative
healthcare choices of each patient and provider, drive the process of discovery as a natural outgrowth of
patient care, and ensure innovation, quality, safety, and value in healthcare.”
Vanderbilt is committed to continuing in the development of a cadre of scientists formally trained and well
versed in best methods for integrating scientific discovery, evidence implementation, and evaluation of health
policies within the learning healthcare system. We have a strong track record of training fellows and improving
patient outcomes. We propose to renew the Vanderbilt Patient, pRactice Outcomes and Research in
Effectiveness and Systems Science (PROgRESS) Program to cross train post-doctoral investigators with a
focus in the learning healthcare system's three core disciplines: 1) Patient Centered Outcomes Research - To
determine which strategies are most effective for patients; 2) Implementation Science - To implement and
evaluate those effective strategies into practice; and 3) Health Policy/ Community Health - To influence policy
to benefit all patients and improve health of the population and community.
By cross training researchers, we will draw together groups of trainees and mentors to model team science.
We provide role models to junior investigators and forums that demonstrate the intellectual productivity and
practical benefits of interdisciplinary research in advancing human health. We endorse team approaches to
filling gaps in knowledge and translating knowledge into application that leads to improvement in the
populations' health. A robust and diverse pool of talented applicants is available with more applicants each
year than spaces available in the program. We have a thriving Implementation Science program, a well-
positioned Department of Health Policy, and diverse partners including Meharry Medical College and
Vanderbilt University School of Nursing.
PROgRESS trainees will continue to access faculty mentors with sustained federal funding who have an
extensive track record of mentoring trainees. Each trainee's Scholarship Oversight Committee (SOC) will draw
from an experienced pool of mentors in the three areas of focus: Patient Centered Outcomes Research,
Implementation Science, and Health Policy/Community Health. The program will continue to provide: 1)
advanced didactics, including a degree program or focused classwork; 2) formal mentorship that prepares
trainees for K-level training; and 3) experiential learning through the conduct of a research project. Trainees
will be supported by a broad array of institutional resources for training and development, including: Work in
Progress, Clinical Quality and Implementation Research Scholarly Series and journal clubs, Biostatistics
Seminars, clinical and translational seminars, and peer-mentoring activities. Taken together, these resources
provide an optimal environment for developing the next generation of learning health system scientists.

Public health relevance
PROJECT NARRATIVE The learning healthcare system is designed to “generate and apply the best evidence to optimize the collaborative healthcare choices of each patient and provider, drive the process of discovery as a natural outgrowth of patient care, and ensure innovation, quality, safety, and value in healthcare.” Vanderbilt is developing investigators in multiple disciplines, who are formally trained and well versed in best methods for engaging and improving the learning healthcare system. We propose to continue training future investigators in the Vanderbilt Patient, pRactice Outcomes and Research in Effectiveness and Systems Science (PROgRESS) Training Program in three distinct methodologic areas: 1) Patient Centered Outcomes Research -To determine which strategies are most effective for patients; 2) Implementation Science-To implement those effective strategies into practice; and, 3) Health Policy/ Community Health-To influence policy to benefit all patients and improve the health of the community.